Developing a Brief Intervention for Parental Alcohol Socialization to be Delivered by Pediatric Providers: A Feasibility Study

PROJECT SUMMARY
Children’s first exposure to alcohol often occurs within their homes, under the supervision of their parents.
Early onset alcohol use and permissive parental attitudes about adolescent alcohol use predict subsequent
alcohol problems. Family-oriented preventive interventions are generally most effective, but most interventions
are delivered in schools. Home-based family interventions are resource intensive and difficult to implement on
a wide scale; thus, their reach and sustainability are limited. The long-term objective of this R34 Planning Grant
is to develop and assess feasibility of an initial version of the Brief Intervention to Prevent Alcohol Socialization
(BI-PAS), which will be delivered to parents of rising 6th graders by pediatric healthcare practitioners during the
annual well-child visit. Messages contained within the brief encounter with providers will be bolstered by
weekly text messages that contain tailored intervention content based on parents’ self-reported attitudes about
adolescent alcohol use. As a primary care-based intervention, BI-PAS will have a wide reach because of the
non-stigmatizing intervention context. Entry into middle school is the ideal time for a primary care-based
intervention because the schedule of required booster immunizations ensures access to difficult-to-reach
populations. Furthermore, this intervention may provide a way to meet American Academy of Pediatrics
standards regarding anticipatory guidance for parents about adolescent alcohol use. We have two specific
aims. First, we will develop and optimize the BI-PAS intervention message content and delivery through semi-
structured qualitative interviews with parents and pediatric providers. Our second aim is to conduct a pilot
study to assess feasibility, implementation, and parental engagement over time. In our design, we will recruit
providers in two large pediatric clinics (one treatment clinic and one comparison clinic). We will train all
providers from the treatment clinic to implement BI-PAS with 50 parents of rising 6th graders. The 50 parents in
the comparison group will follow the same study protocol as the treatment parents but will not receive the
provider intervention or tailored text messages. All 100 parents in the study will complete repeated
assessments of alcohol-related attitudes and behaviors at baseline and monthly for 6 months after baseline.
Treatment families will receive weekly intervention messages that are tailored based on their most recent
assessments. Providers will use implementation checklists to track implementation quality. They will also
participate in a follow-up interview at the conclusion of the study to assess feasibility and barriers to
implementation. Primary analyses will assess implementation of intervention components, parental
engagement with intervention material over time, BI-PAS implementation quality, and change in permissive
parental attitudes over time in the treatment group compared to the control group. The expected outcome of
the proposed research is the development of an intervention that can be tested in a randomized control trial of
short- and long-term parent and child outcomes with a large, generalizable sample.

Public health relevance
PROJECT NARRATIVE The intervention that we propose to develop is based on evidence that alcohol socialization occurs early, within the family context. Our intervention approach capitalizes on high levels of parental trust in pediatric healthcare professionals to develop a low-cost, high reach, and sustainable intervention to prevent early onset alcohol use.